The Center for Innovation in Intensive Longitudinal Studies (CIILS)

PROJECT SUMMARY
The Intensive Longitudinal Behavior Network (ILHBN) provides an unprecedented
opportunity to advance and shape the future landscape of health behavior science and
related intervention practice. The Center for Innovation in Intensive Longitudinal Studies
(CIILS), housed at the Pennsylvania State University (Penn State), brings together an
interdisciplinary team to synergistically support and coordinate research activities across
a diverse portfolio of anticipated U01 projects to accomplish the Network's larger goal of
sustained innovation in the use of intensive longitudinal data (ILD) and associated
methods in the study of health behavior change and health-related interventions. The
proposed administrative supplement will provide CIILS with a one-year extension with
funds to continue coordination of ILHBN activities, and enhance the collective impacts of
the Network by accomplishing the following aims. First, we will continue to manage all
administrative and regulatory aspects of ILHBN. Second, we will collaborate with the
U01 sites to synergistically advance the science of health behavior theory and
intervention practice by helping to compile, curate, harmonize, share, and analyze data
pooled across several parent projects to address common cross-study questions of
interest. Third, we will lead a cross-study project to explore missing data patterns and
modeling methods for self-report affect and sensor-based movement data.

Public health relevance
PROJECT NARRATIVE This project proposes a one-year extension with funds to allow the Center for Innovation in Intensive Longitudinal Studies (CIILS), housed at the Pennsylvania State University, to continue its role as the Research Coordinating Center (RCC) for the Intensive Longitudinal Health Behavior Network (ILHBN). Our interdisciplinary team – consisting of social scientists with expertise in design and management of intensive longitudinal studies; methodological experts who are leading figures in developing novel within- person analytic techniques; health theorists and prevention/intervention experts well- versed in the translation of health theories into within-person health intervention; cyberscience experts with expertise in collection of digital footprints, data security and data sharing issues; and administrative personnel with expertise in management and coordination of network activities – is uniquely poised to advance and sustain the collective innovations of the ILHBN by synergistically supporting and coordinating research activities across a diverse portfolio of U01 studies and cross-study projects.